Immune interactions with commensal microbes in early life

Project Summary/Abstract
Events in early life, particularly those altering the gut microbiota and immune development, can have an
important role in determining future risk of immune related disorders. For example, it has been reported that the
how substances are encountered by the immune system, the timing of feeding practices, hygiene, and the use
of antibiotics, in early life can modify the risk of immune driven disorders later in life. A common theme amongst
many of these studies is that these risk factors likely affect the developing microbiota. However, the biologic
basis for how early life microbial changes can affect the risk of immune disorders later in life is incompletely
understood. Previous data from our laboratories have suggested that during this preweaning period, specific live
gut bacteria are selectively delivered to the immune system and that interaction of these live bacteria with cellular
immune populations locally in the colonic lamina propria or in distant lymphoid tissues establishes a durable (life-
long) and balanced immune system. In preliminary studies, we observed substantial variance in the amount of
bacterial translocation in this preweaning period, which was corroborated with studies of antigen-specific T cell
responses to a translocating bacterial spp. We therefore hypothesize that the magnitude and quality of the
immune response to these translocating bacteria species during the preweaning period is a stochastic event
during normal ontogeny which represents an important variable in determining whether an individual establishes
a balanced immune system and prevents immune mediated pathologies in later life. However, the nature of
these translocating bacteria and methods to quantify the antigen-specific responses to these bacteria remain a
gap in our knowledge. We will address this question by identifying and characterizing how the translocating
bacteria are encountered by the immune system (Aim 1) and generate reagents to track bacterial antigen
presentation via T cell responses in vivo (Aim 2). We will use these reagents to integrate the immune response
over the preweaning period to translocating bacterial spp. during physiologic development and correlate it with
intestinal immune challenges including infection and experimental colitis in later life (Aim 3). If successful, this
project may reveal that preweaning translocation is an important stochastic developmental variable involved in
generating intestinal immune health and homeostasis.

Public health relevance
Project Narrative Events in early life involving the gut microbiota can have an important impact on immune development altering the risk of immune related disorders. For example, it has been reported that the route of delivery, feeding, hygiene, and antibiotics, in early life can modify the risk of inflammatory bowel disease and allergic outcomes later in life. This proposal seeks greater understanding of the gut commensal bacteria that impact immune development and address whether the extent of this interaction dictates durable immune homeostasis and resistance from pathologic immune outcomes in later life. These data on physiologic immune development may inform on risk of developing inflammatory bowel disease or other immune conditions in humans.